OD THE DATAWORKS PRIZE CHALLENGE AWARD HHS-CAOD-2022-OD-ODSS-001

The National Institutes of Health (NIH) is championing a bold vision of data sharing and reuse. The DataWorks! Prize fuels this vision with an annual challenge that showcases the benefits of research data management while recognizing and rewarding teams whose research demonstrates the power of data sharing or reuse practices to advance scientific discovery and human health. We are seeking new and innovative approaches to data sharing and reuse in the fields of biological and biomedical research.